Drug Repurposing to Accelerate Progress in Neonatal Neuroprotection

Abstract
In childhood, the risks of acute brain injury peak in the neonatal period. Major mechanisms of perinatal brain
injury include hypoxia-ischemia (HI) and inflammation in response to intrauterine (e.g. chorioamnionitis) or
neonatal (e.g. necrotizing enterocolitis) infections. In term infants, antecedent hypoxic-ischemic events can
often be discerned; in premature neonates, multifactorial contributing mechanisms are often more difficult to
identify. In view of the significant neurologic morbidity associated with perinatal brain injury in both term and
preterm infants, effective neuroprotective interventions are greatly needed. Many drugs decrease brain injury
and improve functional outcome in neonatal rodent hypoxic-ischemic (HI) brain injury models. A major
translational challenge is to select those to prioritize for advancement to complementary larger animal perinatal
injury models, and ultimately to early stage human neonatal trials. In view of the time lag from new drug
development to clinical trials, our strategy is to prioritize evaluation of potentially neuroprotective drugs that are
already approved for other indications i.e. “repurposing”, and utilize an “adaptive platform design model” for
comparative efficacy studies. This proposal builds upon our recent findings that treatment with a clinically
available antibiotic, azithromycin (AZ), reduces brain damage and improves functional outcomes in multiple
neonatal rodent hypoxic-ischemic (HI) brain injury models. Our aims are to compare neuroprotective efficacy
among clinically available drugs, including AZ, that are neuroprotective in similar neonatal rodent models, to
help prioritize the best candidate(s) to advance to human trials. Efficacy will be compared in well-characterized
rat models of hypoxic-ischemic and inflammation-amplified hypoxic-ischemic brain injury. We will incorporate
studies in two age groups, post-natal day 7 (P7), to model term brain development, and P3, to model
premature neonates. To elicit unilateral forebrain injury, animals undergo unilateral carotid artery ligation and
subsequent timed (45-90 min) exposure to 8% oxygen; this results in quantifiable sensorimotor deficits and
unilateral brain tissue damage. Pro-inflammatory stimuli, e.g. injections of a TLR-4 (lipopolysaccharide, LPS)
or a TLR-2 (Pam3CSK4) agonist prior to lesioning, amplify HI injury. Our preliminary studies showed that
treatment with AZ confers dose and time-dependent neuroprotection, at both ages, vs. HI and inflammation-
amplified HI injury. Our current goals are to compare the neuroprotective efficacy among multiple clinically
available drugs (AZ, erythropoietin, melatonin, sildenafil, caffeine, topiramate) in P7 (Aim 1) and P3 (Aim 2) rat
hypoxic-ischemic and inflammation-amplified hypoxic-ischemic brain injury models. We quantify protective
efficacy with composite scores that incorporate lateralizing sensorimotor function, memory and neuropathology
measures, and also account for death as a possible injury outcome. We hypothesize that these comparative
efficacy studies will identify one or two drugs with the highest probability of superiority at each age, and thus
accelerate progress towards advancing safe and effective drugs to clinical trials in term and preterm neonates.

Public health relevance
Project Narrative In childhood, the risk of acute brain injury peaks in the neonatal period and neonatal brain injury can result in life-long significant neurologic disabilities. Major contributors to neonatal brain injury include hypoxic-ischemic events during labor and delivery and inflammation resulting from intrauterine or neonatal infections. In experimental animal models, many drugs reduce brain injury resulting from hypoxic-ischemia and inflammation, and we propose to directly compare the neuroprotective efficacy of clinically available drugs in neonatal rodent brain injury models to identify those that should be prioritized for further study.